TJU-JNMC Global Network for Women's and Children's Health Research Unit

Project Summary/Abstract
Building on a history of more than two decades of successful collaboration among Thomas Jefferson University
(TJU), Jawaharlal Nehru Medical College (JNMC), and the NICHD Global Network for Women's and Children's
Health Research, we seek to ensure the continued growth, development, and sustainability of our partnership
via the next cycle of the Global Network (GN). Specific project aims include:
• Provide experienced leadership within the GN fostering innovation, research excellence, and conduct of
common protocols addressing major causes of maternal/child morbidity/mortality in LMICs, and incorporating
implementation research aiming to scale up successful interventions and influence public health policy;
• Identify and address gaps in maternal and child health research, utilizing a team-based approach to
design, develop, implement, and evaluate promising health interventions, focusing on those addressing public
health crises that impact the health of pregnant/lactating women and their offspring, and promoting progress
toward achievement of the NICHD Strategic Plan 2020 and the 2030 Sustainable Development Goals for
maternal, newborn, and under-5 mortality, and, as appropriate, health financing, and workforce development;
• Engage local stakeholders by continuing to involve the Ministries of Health at the local, state, and national
level; incorporating ASHA workers and auxiliary nurses into the research team (with approval of the MOH);
and establishing a local Community Engagement Board comprising lay community members to provide local
perspective on research outcomes of most benefit to participants, support dissemination of research findings,
and promote translation of research evidence into practice;
• Expand research capacity and catchment areas within Karnataka, as well as to other states in India –
specifically Maharashtra, Rajasthan, and Odisha – resulting in greater generalizability of findings to all regions
and populations of the country and other low resource settings globally;
• Conduct GN approved common protocols with high recruitment and retention rates encompassing a
range of study designs (e.g., RCTs, formative, translational, mixed methods, observational, and
implementation research) initiated by GN investigators, as well as those proposed by outside investigators;
• Apply the guiding principles of NICHD-supported multi-site clinical research which are: 1) Enhance rigor
and reproducibility, 2) Promote greater availability of multisite clinical trial infrastructure to support trials from a
wider range of investigators, 3) Facilitate data sharing and access to biospecimens, 4) Facilitate greater
involvement of diverse populations in multisite clinical trials;
• Disseminate research findings with the goal of influencing health policy and system changes and to scale
up evidence-based interventions to promote meaningful and sustainable health improvements.

Public health relevance
PROJECT NARRATIVE The Thomas Jefferson University - Jawaharlal Nehru Medical College (Belagavi, India) Women's and Children's Health Research Unit collaboration represents a most productive academic partnership for the conduct of clinical research; for educating students, fellows, and junior faculty; and in fostering enhanced research capacity building. We are poised to utilize new technologies, shared datasets, artificial intelligence, biobanking, microbiome assessments, placental histopathology, and new surveillance techniques to address global challenges, with India often having the highest prevalence of adverse maternal, neonatal, and infant outcomes.